DEFINING REGULATORY ROLES FOR HISTONE H3 METHYLATION IN DEVELOPMENT

Project Title: Defining regulatory roles for histone H3 methylation in development
Principle Investigator: Justin Brumbaugh, University of Colorado Boulder
I am submitting this document is to apply for an administrative supplement to my NIH R35 (R35GM142884)
award entitled, “Defining regulatory roles for histone H3 methylation in development.” This request is in
response to NOT-GM-22-017 (PA-20-272).
Financial status of current grant. I was awarded an early-stage investigator R35/MIRA grant in July 2021. I
am currently in the first year of the funding period. As a result, we do not yet have unobligated funds to report;
however, based on our current spending rate, we anticipate that we will have approximately $20,000-$40,000
of unobligated funds to carry into year 2, most of which are a result of COVID-related lab restrictions. We plan
to use these funds to sequence large-scale genomics samples that we have collected over the past months
and are awaiting analysis.
Parent Award Summary
Project summary. Pluripotent stem cells hold tremendous scientific and therapeutic potential because they
have the capacity to differentiate into any cell in the adult body. Mounting evidence suggests that differentiation
is driven, in part, by epigenetic mechanisms such as histone modifications that help to establish and
subsequently maintain cell identity. However, demonstrating a direct role for an individual histone modification
is challenging via traditional mutagenesis approaches because multiple copies of canonical histone genes are
present in the mammalian genome. Moreover, many histone marks are regulated by several, redundant
enzymes, which are difficult to perturb simultaneously and in a physiological context. The long-term goal of our
research is to resolve the role of histone modifications in directing cell fate, both in vivo and in tissue culture
systems. Our approach is innovative because it overcomes current limitations in the field by taking advantage
of lysine-to-methionine (K-to-M) mutations on histone H3, which act as dominant negative inhibitors of
methylation at their respective sites. The objective of this grant is to characterize the function of methylation on
residues H3K9 and H3K36, which change dramatically during differentiation and development. Our central
hypothesis is that H3K9 and H3K36 methylation have distinct and crucial roles in developmental transitions. To
test this hypothesis, we will express mutant histones, H3K9M and H3K36M, in early embryos and pluripotent
stem cells. Specifically, we will track the maternal to zygotic transition and early lineage decisions following
suppression of H3K9 and H3K36 methylation in embryos. We will then apply in vitro cell culture systems to
investigate the molecular basis for the effects of K-to-M mutants on chromatin and gene expression. A key
feature of our approach is that expression of the mutant histones is doxycycline-inducible, which permits
induction or withdrawal of our histone mutants in a tissue- and time-specific manner. Using this tool, we will ask
whether cells are capable of reestablishing histone modifications to rescue proper differentiation after mutant
histone withdrawal. Collectively, this work is significant because it will provide valuable insight into the
functional role of histone modifications in cell fate change. Understanding the regulatory mechanisms that
control stem cell function is a crucial step in realizing their tremendous potential. We therefore anticipate that
the proposed work will have important implications for both basic science and medicine.
Brief progress to date (current status). The primary aims of our parent grant are to clarify how particular

Public health relevance
In principle, stem cells can be directed to produce desired cell types for transplantation, disease modeling, and drug testing, which is the basis for their tremendous scientific and therapeutic potential. However, we have not yet realized this potential because we do not fully understand the regulatory mechanisms that maintain stem cells and instruct their differentiation. The research outlined in this proposal will define the regulatory role of methylation at two key histone residues, H3K9 and H3K36, in directing differentiation, both in vitro and in vivo.